ST6GalNAc-I/MUC5AC promoting angiogenesis in lung adenocarcinoma

Abstract
Non-small cell lung cancer (NSCLC) is an aggressive disease accounting for approximately 85% of all lung
cancers. Despite recent advances, the overall 5-year survival rate remains dismal for NSCLC patients. Lung
adenocarcinoma (LUAD) is the most common subtype of NSCLC. A high incidence of LUAD displays an
aggressive disease, frequent metastasis and is associated with poor prognosis. Hence, understanding the
mechanisms behind LUAD angiogenesis, tumor development, and metastasis would significantly improve LUAD
outcomes. The unique expression of St6galnac-I was identified in aggressive type (KrasG12D/+; Trp53R172H/+; Ad-
Cre (KPA)) autochthonous tumors. ST6GalNAc-I is an O-glycosyltransferase, which catalyzes the addition of
sialic acid onto first sugar GalNAc (Tn) and results in the formation of Neu5Acα2, 6GalNAc (STn) carbohydrate
antigen. ST6GalNAc-I KO cells showed a reduced level of sialylated MUC5AC in LUAD cells, and ST6GalNAc-
I KO or MUC5AC knockdown (KD) cells had less angiogenesis and migratory potential. In particular, MUC5AC
KD LC showed significantly reduced organ-specific endothelial binding and tube formation ability in both lung
(HUVEC) and brain (HBEC-5i). Based on these studies, we hypothesize that “ST6GalNAc-I alters MUC5AC
glycosylation in the LUAD tumor microenvironment and promotes angiogenesis in both the primary tumor and
metastatic sites through integrin β4.” To test this hypothesis, two specific aims are proposed. Aim 1 will
comprehensively define the impact of ST6GalNAc-I on MUC5AC glycosylation and its impact on tumor growth
and angiogenesis. Aim 2 will systemically delineate the molecular mechanism of ST6GalNAc-I mediated
MUC5AC glycosylation and their role in the tumor microenvironment in both primary and metastatic sites,
especially brain metastasis, using available mouse models. To prove this concept, we will use ST6GalNAc-I KO
or MUC5AC KO cell lines, transthoracic and intracardiac metastatic models, and Muc5ac knockout mouse
models. We will also use 3D organoid models to study the interaction of MUC5AC expressing tumor cells and
non-tumor cells in primary and metastatic sites. It will highlight the mechanistic and functional significance of the
ST6GalNAc-I/MUC5AC axis in cellular adhesion and metastasis. The major impact of the proposed study would
be to provide the impact of ST6GalNAc-I on MUC5AC sialylation and the role of this pathway in tumor growth
and angiogenesis. The outcomes from the study will help to design novel therapeutic strategies for metastatic
LUAD patients.

Public health relevance
Project Narrative Non-small cell lung cancer (NSCLC) is an aggressive malignancy, and available treatment options are limited. Understanding the molecular mechanism for lung cancer progression is key to improving outcomes. In this proposal, we will analyze the role of ST6GalNAc-I on MUC5AC glycosylation and its impact on angiogenesis in NSCLC. These studies will help us to develop novel therapies for preventing lung adenocarcinoma metastasis.